High-resolution analysis of chromatin regulation by the Max network

PROJECT SUMMARY Transcription factors (TFs) are DNA binding proteins that link information encoded in the genome to regulation of transcription and chromatin, which is the complex of proteins and DNA that constitutes the epigenome. The mechanisms by which TFs regulate chromatin structure are not well characterized. The Max network, which includes the Myc oncoproteins, is composed of TFs that function through heterodimerization with the TF Max. This network is important in development and has been implicated in as many as 70% of human cancers. Genomic binding of the entire Max network has not been mapped and existing maps of Myc binding have led to a complicated picture of network function. Myc binds pre-established euchromatic regions and its depletion leads to collapse of active chromatin and decrease in accessibility, suggesting a role for Myc in regulating chromatin structure. However, roles for other Max network members in regulating epigenome structure are not known. Intriguingly, the Max network has been shown to interact with chromatin modifying complexes, yet the functional significance of these interactions has not been evaluated. Three specific aims are proposed to dissect the regulation of chromatin structure by the Max network in a human B cell line model of Burkitt's lymphoma. In Specific Aim 1, genome-wide binding of the Max network will be mapped at single- base resolution and the effects of Myc dosage on Myc binding will be determined. In Specific Aim 2, the relationship between chromatin structure and the Max network, as well as the effect of Max network member depletion on the epigenomic landscape, will be determined. Additionally, Max network members will be mapped after depletion of Max to explore the possibility of network function independent of Max heterodimerization. In Specific Aim 3, the functional consequences of physical interactions between the Max network and chromatin remodeling and Polycomb repressive complexes will be studied. The proposed studies will leverage a high-resolution native epigenome mapping approach to provide insights into how transcriptional regulatory networks interpret information encoded in the base-pair sequence of the genome to shape the chromatin landscape. Given the central role of the Max network in transcriptional control of growth and proliferation, the proposed studies may have implications for understanding molecular mechanisms underlying both normal development and disease.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the Max transcription factor network, which includes the Myc proteins that regulate cell growth, proliferation, and cell death. The Max network is dysregulated in the majority of human cancers. The experiments in this proposal aim to understand the causal mechanisms by which the Max network shapes the structure of chromatin, the protein-DNA complex that makes up chromosomes. A clear understanding of the biology of Max network function will be important for diagnosis and treatment of cancers. __SpecificAimsTextDelimiter__ High-resolution analysis of chromatin regulation by the Max network SPECIFIC AIMS Project Overview. Transcription factors (TFs) are sequence-specific DNA binding proteins that interpret information encoded in the genome to regulate transcription and chromatin structure; however, causal mechanisms by which TFs shape the epigenomic landscape are not well characterized. The Max network is a TF network that includes the Myc oncoproteins and other TFs that heterodimerize with the TF Max. This network integrates mitogenic signaling with regulation of transcription and chromatin and thereby acts as a key regulator of growth and proliferation. The Max network interacts with ATP-dependent chromatin remodelers (CRCs) and Polycomb repressive complexes (PRCs), although the significance of these interactions has not been systematically investigated. The proposed studies seek to understand the interplay between the Max transcriptional network, CRCs, and PRCs and are expected to further the understanding of how TF networks interpret information encoded in the genome to shape the chromatin landscape. Given the central role of the Max network in growth and proliferation regulation, these studies may provide insight into molecular mechanisms underlying network function in normal development and cancer, where as many as 70% of cancers are associated with Max network dysregulation. Specific Aim 1: Map the Max network in a cell line model of Burkitt's lymphoma. Chromatin immunoprecipitation (ChIP) studies have inspired a complicated view of widespread Myc binding and the binding of other network members has not been mapped. Furthermore, despite the importance of Myc overexpression in cancer, it is not known how Myc dosage alters binding site preferences. Studies of the Max network are further limited by current ChIP methodologies, whose artifacts include low resolution, high false positive rate, and a bias towards accessible chromatin stemming from formaldehyde crosslinking and sonication. In this Specific Aim, I will build on preliminary data, which indicate the applicability of a novel native epigenome profiling approach that does not rely on cross-linking or sonication, to map the entire core Max network at base-pair resolution in the P493-6 human B cell line model of Burkitt's lymphoma. Additionally, I will exploit the controllable nature of Myc expression in this cell line to determine changes in Myc binding at various Myc levels. These experiments will yield the first comprehensive, high-resolution maps of the core Max network and provide insight into how Myc overexpression in cancer may alter chromatin and transcription. Specific Aim 2: Determine the relationship between the Max network and chromatin structure. Myc is known to bind pre-established euchromatic regions and its depletion causes chromatin structural changes consistent with silencing, suggesting a role for Myc in maintenance of epigenome structure. However, this possibility has not been evaluated on a genome-wide scale, particularly given that the interplay between other Max network members and chromatin structure is unknown. Recent work has also provided evidence of Max network function independent of heterodimerization with Max. In this Specific Aim, I will determine the relationship between chromatin features, such as histone modifications, and Max network binding. I will also knockdown Max network members and determine the effects of network member depletion on the epigenome. Finally, I will determine whether Max network members can bind independent of Max. These studies will provide a high-resolution picture of the functional consequences of Max network member binding on epigenome structure and will explore the possibility of heterodimerization-independent network function. Specific Aim 3: Characterize the significance of Max network interactions with chromatin remodeling and Polycomb repressive complexes. Max network members are known to interact with both CRCs and PRCs; however, it is not known whether these interactions are functionally significant. The experiments proposed in this Specific Aim build on preliminary data suggesting a role for the CRC SRCAP, which is involved in exchange of the histone variant H2A.Z, in Myc-driven lymphomagenesis and the applicability of native epigenome profiling methods to the study of CRCs and PRCs. In order to test the hypothesis that Max network members differentially recruit chromatin modifiers, I will determine which Max network members interact with two specific CRCs - SRCAP and SWI/SNF - as well as PRCs. I will then ascertain which regions of Max network members are responsible for direct interactions with these complexes using a simple in vitro peptide mapping approach. The in vivo functional significance of direct interactions will be evaluated by determining whether Max network member deletion mutants can disrupt localization of CRCs and PRCs in P493-6 cells. The studies proposed in this Specific Aim will delineate the functional significance of Max network-chromatin modifying complex interactions and therefore provide insight into mechanisms by which TFs shape the epigenome.